Integrative Genomics and Bioinformatics Core (IGC)

PROJECT SUMMARY – INTEGRATIVE GENOMICS AND BIOINFORMATICS
The Integrative Genomics and Bioinformatics Shared Resource (IGC) provides analytical, computational, and
technical services for all types of -OMICS (e.g., genomics, metabolomics and proteomics) research performed
by Salk Cancer Center (SCC) members. In the era of big data in biology, bioinformatics analysis is crucial for
deriving biological insights from large and noisy high-throughput data. The goal of the IGC has been to provide
SCC members access to state-of-the-art bioinformatics expertise and support. Staff in the IGC assist SCC
members with integrative analysis of sequencing datasets, provide software and tools that SCC members can
use to perform their own analyses, provide training in software use, and develop customized tools and pipelines
for cutting-edge analyses. As needed, they also develop new tools and techniques for SCC members whose
projects push the boundaries of research, generate publication quality visualizations of analyses, and help
prepare scientific manuscripts and grants containing bioinformatics or genomics components. The IGC is used
by 20 SCC members (65%) accounting for 49% of the services utilized.